Moffitt Cancer Center Support GrantDeterminants of Cancer Survivorship Among People Living with HIV (HIV/AIDS/Aging Cancer)

PROJECT SUMMARY
With the advent and widespread use of highly active antiretroviral therapy, people living with HIV (PLWH) are
living longer and are aging into demographics at higher risk of developing cancers not traditionally linked with
HIV or AIDS known as, non-AIDS defining cancers. PLWH are more likely to experience non-AIDS defining
cancer-specific mortality compared to their HIV-negative counterparts. Unequal delivery of cancer care across
the continuum may contribute to the disproportionate burden of both morbidity and mortality associated with
cancer among PLWH. Cancer survivorship care is an integral part of high-quality cancer care and should begin
at cancer diagnosis throughout the cancer care continuum to address several aspects of the cancer treatment
experience including side effects, financial hardship, mental and physical health, health promotion, and
continued surveillance of cancer progression or secondary cancer. Equitable receipt of cancer survivorship care
can improve long-term outcomes such as survival and quality of life, however, little is known regarding delivery
of survivorship care to PLWH in the U.S Research to inform the optimal model of survivorship care delivery for
HIV-positive cancer survivors is particularly urgent due to the complexity that may arise from multi-level factors
impacting PLWH in the U.S. including the unique social issues and biological sequalae of living with HIV as a
chronic disease, however, currently limited research exists. To fill this gap in scientific knowledge, we will
leverage longitudinal data collected from the MACS/WIHS Combined Cohort Study (MWCCS), the longest US
longitudinal study of PLWH (Aims 1 & 2), as well as data collected prospectively from HIV-positive cancer
patients treated at one NCI-designated cancer center in a high burden HIV state (Aim 3) to carry out the following
specific aims: (1) Aim 1: Estimate differences and identify determinants (clinical, behavioral, and social) of cancer
survival among non-AIDS defining cancer survivors living with and without HIV; (2) Aim 2: Evaluate longitudinal
changes in individual-level clinical (e.g., general comorbidities, adherence to ART), physical (e.g., frailty,
activities of daily living), and psychosocial (e.g., depression, quality of life) outcomes after a non-AIDS defining
cancer diagnosis and whether these changes differ by HIV status; and (3) Aim 3: Explore the role of patient
cancer care quality on cancer survivorship outcomes among people living with and without HIV with a non-AIDS
defining cancer diagnosis. Taken together, successful completion of these aims will lead to the identification of
intervenable opportunities to improve cancer survivorship outcomes among PLWH. This preliminary work will
inform future large-scale projects to design and implement cancer survivorship care plans to ultimately improve
cancer survivorship outcomes (specifically survival and quality of life) and reduce the inequitable burden of
cancer deaths among PLWH.

Public health relevance
PROJECT NARRATIVE People living with HIV with a cancer diagnosis experience elevated cancer-specific mortality and worse cancer outcomes compared to their HIV-negative counterparts. Inequities in cancer survivorship care and associated outcomes, such as quality of life, may contribute to disproportionate cancer-specific deaths among PLWH, however, this remains an understudied area of investigation. To inform the development of equitable strategies to deliver cancer survivorship care plans to HIV-positive cancer patients, the current study will evaluate multiple aspects of the cancer survivorship experience among PLWH, including the role of cancer care delivery and HIV- specific barriers to high quality care such as stigma, on associated outcomes such as survival, mental health, and quality of life.